The Hopkins Undergraduate Summer Training and Research (USTAR) Program

As the US undergoes a demographic transition to a larger and more racially and ethnically diverse older adult
population, significant disparities in aging-related diseases will persist. Despite decades of research focusing
on health disparities and minority health as it relates to aging, there has been minimal interdisciplinary
research with emphasis on advancing research and policies focused on health disparities and minority health
in middle to late life using a life-course perspective. Although there are aging- or health disparities-focused
research programs at Johns Hopkins, at present there is no externally funded summer training program that
supports the development of the next cadre of underrepresented undergraduate trainees in health disparities
research as it relates to aging or minority aging focusing on cognitive impairment, Alzheimer’s Disease,
physical functioning, and frailty. The Hopkins Undergraduate Summer Training and Research (USTAR)
Program described herein will sit at the nexus of other complementary aging- and health disparities-related
training programs and Centers at Johns Hopkins. The overarching goal of Hopkins USTAR is to reduce health
disparities and move toward health equity in health outcomes in older adults by increasing the diversity in
aging research by focusing on underrepresented undergraduate students. We are requesting funds to support
8 underrepresented undergraduates per year for a total of 32 who attend our partner institutions full time:
Morgan State University, and University of Maryland Baltimore County. There are 31 program faculty, drawn
from the Departments of Health, Behavior, and Society, Mental Health, Health Policy and Management,
Epidemiology, Biostatistics, School of Medicine, and the School of Nursing at Johns Hopkins University. The
scientific leadership, infrastructure, collaborative nature, and collegial environment provided by these research
programs and program faculty will enable the provision of broad exposure to all undergraduate trainees to the
tenets of health disparities across the life course and minority aging to several age-related diseases such as
cognitive impairment, Alzheimer’s Disease, physical disability, and frailty. Specific aims include: (1) Train the
next cadre of health disparities and minority aging researchers by ensuring hands-on participation in
interdisciplinary, age-related research by providing trainees with a research project focusing on health
disparities and/or minority aging across the life course as it relates to cognitive impairment, Alzheimer’s
Disease and related dementias, physical functioning, and frailty; (2) Provide research education in health
disparities and minority aging across the life course as it relates to physical and mental health outcomes; (3)
Implement career development opportunities, through individualized mentorship and by leveraging the
leadership and career development resources across the Institution, to prepare trainees to begin their next
career transition; and (4) provide an external evaluation of the outcomes and process of the Hopkins USTAR
program.

Public health relevance
The proportion of the US population aged 65 years and older and the number of aged minorities is increasing rapidly; with this demographic shift, significant racial/ethnic disparities remain in age-related conditions such as cognitive impairment, Alzheimer’s Disease, physical disability, and frailty. There is a great need to ensure that the research workforce in aging is representative of the US population. The Hopkins USTAR will provide mentored research experiences, research education, and career development skills in MSTEM areas related to research in aging for underrepresented undergraduates who are interested in research careers in health disparities and minority aging as it relates to age-related diseases.